Mechanisms of Impaired Renal Hemodynamics after Spinal Cord Injury

Mutations in cilia genes drive renal cyst formation in patients and in mouse models of the disease. Multiple forms of renal cystic disease are a leading cause of end stage renal disease and cause considerable morbidity in society. There are no therapies designed to stop cyst formation and the cellular and molecular mechanisms of cyst formation are not well understood. We have identified the ciliary trafficking gene Tulp3 as an essential regulator of renal cystic disease. Mutations in cilia genes have been shown to cause kidney cystogenesis and to perturb the Hedgehog signaling pathway in many in vivo and in vitro contexts. We aim to test whether the activation of the Hedgehog pathway in vivo in renal cells causes cyst formation in a mouse model. Understanding the cellular and molecular mechanisms by which perturbations in cell signaling can initiate the cystic process will be invaluable to our understanding of the disease. A better understanding of the molecular mechanisms of how cyst formation arises will open new strategies to pharmacologically control/contain cystogenesis.

Public health relevance
PROJECT NARRATIVE – RELEVANCE TO PUBLIC HEALTH Approximately 18,000 people suffer spinal cord injury (SCI) every year in the United States. Cardiovascular disease, bladder dysfunction and susceptibility to urinary tract infection (UTI) are major causes of morbidity, poorly quality of health, and mortality for chronically injured individuals with SCI. One of the major contributors to SCI-associated cardiovascular disease and high frequency of UTI is excessive bladder filling due in part to urine overproduction. In this proposal, we will explore how abnormal regulation of blood flow to the kidney as a result of SCI plays a role in urine overproduction and interrogate the potential of inhibiting renal vascular maladaptation to improve kidney function, thereby mitigating excessive bladder filling.